Strengthening Mississippi’s Integrated Food Safety System by Enhancing Chemical Testing Capabilities

Overall Project Summary
The Mississippi State Chemical Laboratory (MSCL) is ISO/IEC 17025:2017 accredited (No. 90603) and
operates as both a state regulatory agency and a fee-for-service laboratory. MSCL ensures the quality and
safety of human foods, animal feeds, fertilizers, pesticide formulations, agricultural limes, and petroleum
products sold in Mississippi.
Building on achievements from initial FDA Laboratory Flexible Funding Model (LFFM) support, MSCL seeks to
further expand its analytical scope and strengthen partnerships with federal and state entities, thereby
enhancing the state’s capacity to identify and mitigate chemical contaminants in food and feed. This proposal,
“Strengthening Mississippi’s Integrated Food Safety System by Enhancing the Chemical Testing Capabilities,”
submitted in response to FOA RFA-FD-25-007, aims to further expand MSCL’s capacity. The long-term
objectives of this proposal include bolstering surveillance for emerging food and feed contaminants, reinforcing
laboratory infrastructure to maintain high-quality analytical services, and promoting collaborative partnerships
among state and federal agencies. In line with these objectives, MSCL has identified three specific aims:
1. Expand both compounds of interest and matrices in currently accredited methods to detect a broader
range of emerging contaminants and toxins in food and feed. By enhancing instrument sensitivity and
optimizing workflows, MSCL will improve sample throughput and efficiency, ultimately supporting
proactive surveillance and quicker response times.
2. Strengthen laboratory infrastructure by investing in advanced equipment, staff training, and quality
assurance measures to maintain and elevate MSCL’s capacity for high-quality analyses. These efforts
will provide robust data to inform regulatory actions and protect agricultural interests within the state.
3. Enhance collaborative partnerships by participating in multi-laboratory proficiency testing, engage with
peer laboratories to exchange best practices, and maintain close coordination with state and federal
entities for joint investigations, leading to rapid identification and mitigation of contamination incidents to
foster a safer, more integrated food safety system.
To achieve these goals, MSCL will implement a research plan that includes participating in proficiency testing
and performing analysis of emerging contaminants in samples in preparation for food defense. Staff will
receive ongoing training with peer laboratories to ensure consistent application of best laboratory practices.
Through these strategies, MSCL will strengthen its role as a partner in the integrated food safety framework,
providing faster, more reliable chemical testing results that protect both human and animal health against
evolving food and feed safety threats.

Public health relevance
Overall Project Narrative The Mississippi State Chemical Laboratory (MSCL) is a regulatory agency dedicated to enhancing the integrated food safety system of Mississippi to better protect public health, upholding ISO/IEC 17025:2017 accreditation as the foundation for rigorous testing standards and continuous quality improvement. By strengthening collaborations with other state and federal regulatory partners, broadening its surveillance program for human and animal food products, and reinforcing laboratory infrastructure to maintain high-quality analytical services, MSCL aims to ensure the safety of Mississippi’s food and feed supply. Through this opportunity, MSCL will contribute to food security and thereby safeguard the health of Mississippians.